ACTG 175--MONOTHERAPY VS COMBINATION THERAPY WITH NUCLEOSIDE ANALOGUES IN HIV

This study is designed to determine whether two drug therapy of HIV infection is better, the same as, or worse than single drug therapy in preventing a 50% decline in the number of CD4 cells.